The mutagenic chain reaction: a method for autocatalyic gene dissemination

Following a decade of significant strides forward, the global malaria eradication agenda has stalled, due
in part to the accelerating emergence of insecticide-resistant mosquitoes and drug-resistant malarial parasites.
The World Health Organization and others have called for the development of new strategies to help defeat
this devastating disease that infects over 2 million people and killing over 400,000 annually, predominantly
young children in impoverished regions. Gene-drives, which can bias inheritance of desired traits, offer a novel
and promising strategy either to eliminate disease causing insect vectors, or to immunize them against
pathogens. Such super-Mendelian CRIPSR-based gene-drive systems encode bipartite transgenic cassettes
consisting of the Cas9 endonuclease and a guide RNA (gRNA), which directs DNA cleavage at the genomic
site of insertion. In reproductive cells, such targeted cutting of the homologous chromosome results in copying
the drive element at the cleavage site through homology directed repair, resulting in nearly all progeny
inheriting the drive element and its cargo.
My group has contributed to developing the first CRIPSR-based gene drive (or active genetic) systems in
flies, mosquitoes, mammals, and bacteria. We also pioneered allelic-drive systems designed to bias
inheritance of a favored allelic variant at a separate genetic locus. In addition, we have developed, and
extensively tested, two types of self-copying drive neutralizing systems, both of which carry gRNAs, but no
source of Cas9. ERACRs delete and replace gene-drives, while e-CHACRs copy themselves while mutating
and inactivating the Cas9 transgene carried on a gene-drive. Small population cage experiments in flies and
mosquitoes have shown that highly efficient gene-drives rapidly spread through target populations, and that
ERACRs and e-CHACRs can reliably replace (ERACRs) or halt (e-CHACRs) a gene-drive element.
In this grant, we propose first to develop a flexible two-component (split-drive or CHACR) system that can
be genetically converted (or hacked) into a single full-drive system. The split and full drive elements are
inserted into genes essential for viability or reproduction, and also carry recoded cDNAs of the targeted genes
to restore function of those loci. These recoded systems benefit greatly from a phenomenon we discovered
and refer to as lethal/sterile mosaicism, which dominantly eliminates loss-of-function alleles (mistakes) in the
target gene generated by imprecise DNA repair events rather than the intended copying event. Next, we will
develop and test next-generation ERACR and e-CHACRs able to eliminate or halt our recoded-drives, and also
test a self-limiting drive system that slowly targets Cas9 for mutagenesis. In parallel to these drive experiments,
we will delve into the mechanisms and timing of the drive process using a unique set of image-based genetic
elements we have developed. We anticipate that the intellectual advances and implementable game-changing
technologies from these studies will contribute importantly to solving critical global challenges in human health.

Public health relevance
Malaria and other vector-borne diseases impose devastating impacts on global health and human welfare, and new tools are now urgently needed to combat these rebounding scourges. We have been leaders in developing gene-drive or "active genetic" technologies to disseminate favorable traits throughout populations such as factors blocking transmission of malarial parasites by Anopheline mosquitoes. We propose to advance these game-changing tools to develop next-generation drive systems and corresponding neutralization elements required to move this promising technology forward to practical implementation.